A domain-specific approach to falls efficacy and walking activity in individuals with chronic stroke

Summary
Individuals with chronic stroke are characterized by low levels of walking activity, which negatively impacts
post-stroke health and the risk for recurrent stroke. Although walking speed and endurance are logical targets
for improving walking activity, improving them alone rarely translates to more walking activity in the free-living
environment in this group. Individuals with chronic stroke also have low falls efficacy, which includes their
confidence in performing daily activities without falling. Evidence suggests that, if the low falls efficacy of those
with chronic stroke is not addressed, the benefits of improved walking capacity on walking activity won’t be
realized. To date, falls efficacy has been quantified as an aggregate score from self-reported questionnaires,
such as the Activities-specific Balance Confidence (ABC) scale. A challenge to addressing falls efficacy after
stroke is that it is likely comprised of distinct balance domains not reflected by an aggregate score. These
balance domains, including anticipatory control, walking balance, and reactive balance, can be considered
independent targets for rehabilitation. The ABC scale contains questions relevant to each of these domains. By
aggregating the score, however, the ABC scale does not inform the specific balance intervention targets that
could be used to address falls efficacy and, subsequently, walking activity. Our study aims are to 1)
demonstrate that the construct of falls efficacy in those with chronic stroke is comprised of multiple factors
representing distinct balance domains, and 2) demonstrate that falls efficacy has specific, factor-based
relationships with walking activity in those with chronic stroke. These aims will be addressed using secondary
analyses of ABC scale data within the University of Delaware Stroke Studies Registry, as well as baseline ABC
scale and sensor-based walking data from a multi-site clinical trial in those with chronic stroke (PI: Reisman).
To address the first aim, we will conduct a factor analysis of ABC scale questions to objectively identify unique
domains within the falls efficacy construct. To address the second aim, we will predict walking activity volume,
frequency, intensity, and sedentary behavior from factor-specific ABC scale data. The results of this study will
advance the specificity and utility of the ABC scale in characterizing falls efficacy, as well as informing domain-
specific balance targets for improving falls efficacy and walking activity.

Public health relevance
Narrative Evidence suggests that, if the low balance confidence of those with chronic stroke is not addressed, the benefits of improved walking ability on daily activity won’t be realized. This proposal seeks to identify distinct types of balance confidence within a commonly used questionnaire, and then determine how those categories of balance confidence relate to walking activity in those with chronic stroke. This is an analysis of existing data that will inform the specific ways we can improve balance, raise balance confidence, and enable more walking.